HUMAN CEREBROMICROVASCULAR ENDOTHELIUM-- STUDIES IN VITRO

Production of prostaglandin D2 (PGD2) was investigated in cultured endothelial cells derived from capillaries and microvessels (small and large) of human brain using radioimmunoassays, Peptides, catecholamines, thrombin, protein kinase C-activating phorbol ester and calcium ionophore greatly stimulated the secretion of endothelial PGD2. Both vasoconstricting peptides, angiotensin II and arginine-vasopressin-inducible secretion of PGD2 was almost completely abolished by their respective specific receptor antagonists [Sarl, Ala8]-Ang 11 and [1-6(beta-mercapto-beta, beta-cyclopentamethylene propionic acid) 2-0-methyltyrosine. Thus, augmented production of PGD2 by angiotensin II and argininevasopressin is a receptor-mediated event. it also indicates that the EC have specific angiotensin II and arginine-vasopressin (V1) receptors. This study represents the first demonstration of vasoactive peptides modulating PGD2 production in capillary and microvascular endothelium of human brain.